Harnessing EHR to develop a Florida-based Coalition on Cancer Care Inequities among PHIV (Social Determinants of Health and Quality of Cancer Care in HIV-associated Cancers)

PROJECT SUMMARY
In the US, people with HIV (PWH) experience elevated mortality and morbidity due to cancer compared to the
general population. Factors contributing to the disproportionate burden of poor cancer outcomes among PWH is
likely multi-factorial, including inter-connected clinical and social factors. Among other factors, inequities in
cancer treatment delivery to PWH is likely a contributor to low cancer-specific survival rates PWH face in the US.
It is known that PWH are less likely to receive cancer treatment compared to their HIV-seronegative counterparts,
even after factoring important clinical factors such as cancer type and cancer stage at diagnosis. Although
significant prior research demonstrates PWH experience many social barriers to health care, a largely
unexplored area is the role social determinants of health (SDoH) play in inequitable cancer treatment delivery to
PWH. Insights into cancer treatment inequities among PWH in the context of multi-level SDoH, specifically
individual-level factors such as insurance status and race/ethnicity as well as contextual SDoH based on an
individual’s geographic social environment, will provide a critical opportunity to facilitate patient- and provider-
level intervention development tailored to PWH. To address this gap in scientific knowledge, we propose to
leverage a novel electronic health record (EHR)-based linkage of multiple health care systems across the state
of Florida covering 19 million patients and 70% of adults living in Florida, called OneFlorida+. OneFlorida+
presents a novel, unprecedented context to characterize cancer treatment trends in the context of SDoH
impacting PWH given Florida has among the highest rates of cancer in the US, a racially and ethnically diverse
population, and one of the highest HIV incidence rates in the US. Our aims include: Aim 1: Enhance electronic
health record data of patients with HIV and any invasive cancer with individual and contextual-level SDoH
through developing novel NLP tools and linking external exposome databases; and Aim 2: Examine trends and
social inequities in cancer treatment delivery to PWH diagnosed with invasive cancer. The present proposal will
lead to three important outcomes: (1) the development of an interdisciplinary team of investigators dedicated to
improving cancer care delivery and outcomes among PWH, a vulnerable priority cancer patient population in
Florida 16; (2) establishment of the necessary research infrastructure to inform the development of paradigm
shifting interventions; and (3) the discovery of novel insights into the interplay between SDoH, race/ethnicity,
HIV, and cancer outcomes in FL’s context. Taken together, this one-year project provides a necessary foundation
and the opportunity to apply an innovative lens to view important inequities in cancer control, and will provide
timely, critical, policy relevant findings to facilitate interventions for delivery of equitable, high-quality cancer
treatment to PWH in the US.

Public health relevance
PROJECT NARRATIVE Although cancer is a leading cause of morbidity and mortality among people with HIV (PWH), they are less likely to receive any treatment compared to their HIV-seronegative counterparts, even after considering important clinical factors such as cancer type and cancer stage at diagnosis. Despite the documented inequities in general healthcare access PWH experience, limited prior work has investigated the role of multi-level social factors, collectively known as social determinants of health (SDoH), that may impact PWH’s receipt of equitable, high- quality cancer care. Through the present one-year proposal, we set out to develop the necessary infrastructure to address this gap in scientific knowledge, leveraging a novel electronic health record-based linkage of multiple health systems throughout Florida called OneFlorida+ (19 million patients) to gain real world insights into the role SDoH play in cancer treatment receipt among PWH in the US and facilitate the development of future patient or provider-level interventions tailored to the HIV oncology care context.